INTRATHECAL BACLOFEN THERAPY IN STIFF-MAN SYNDROME--DOUBLE-BLIND, PLACEBO TRIAL

To determine the effectiveness of single boluses of intrathecal Baclofen in reducing spaciticity in stiff-man syndrome.